Folic Acid Supplementation and Colitis-associated Colon Carcinogenesis

Project Summary/Abstract
Patients with ulcerative colitis, a form of inflammatory bowel disease, face an increased risk of developing
colorectal cancer. Although advances have been made in the therapeutic management of this disease, much
less attention has been given to the development of cancer preventive strategies for this high-risk population.
Ulcerative colitis patients often develop folate deficiencies that require supplementation with folic acid (FA), a
synthetic form of folate. The effect of FA on risk for colorectal cancer remains unclear and the recent suggestion
that FA supplements may be useful in preventing colitis-associated colorectal cancer is of great concern.
Preliminary studies from this group provide the first evidence that FA supplementation (8 mg/kg diet) causes
a dose-dependent increase in the formation of colorectal tumors in mice with AOM/DSS-induced colitis. Results
from associated RNASeq and in vitro analyses suggest that FA promotes tumorigenesis by activating ERK and
inducing NF-κB signaling in colonic epithelial cells with dysfunctional p53, the gatekeeping event in the
development of colitis-associated cancers. The hypothesis of the proposed studies is that FA supplementation
promotes UC-associated cancer in cells with dysfunctional/mutant p53, but not in cells with wild type p53, via an
inflammatory pathway mediated by ERK and NF-κB. The mechanism by which FA induces tumor formation will
be investigated in Aim 1 using CRISPR engineered isogenic human RKO colon carcinoma cells with varying p53
status (p53+/+, p53-/- and p53+/Mut). The impact of FA and dysfunctional p53 on activation of ERK, NF-κB signaling,
as well as cell cycle progression will be evaluated. In vitro findings will be validated in Aim 2, where
complimentary in vivo analyses will examine the combined effect of FA and mutant p53 on DSS-induced
colitis-associated tumorigenesis and associated biomarkers in p53+/+ and p53+/515A (mutant) mice. In addition,
the impact of high dose FA given prior to the induction of colitis will be examined. Tumor incidence and
multiplicity, as well as degree of intestinal inflammation, will serve as primary endpoints of these studies. Based
on the important contribution of intestinal microbiota to colitis and their ability to synthesize folate de novo, the
impact of FA administration on the diversity and relative abundance of fecal and adherent bacteria within the
intestine of p53+/515A mice with DSS-induced colitis will be examined in Aim 3. Mice will be treated with
5-aminosalicylic acid (5-ASA), a common maintenance therapy for ulcerative colitis, for the duration of FA
exposure to recapitulate the clinical therapy of a patient following a diagnosis of colitis. The composition of the
fecal and colon-adherent microbiomes, determined from 16S rRNA and metagenomic sequencing data, will be
correlated with colonic inflammation, barrier function and tumor incidence/multiplicity. The results are expected
to provide significant insight into the impact of FA supplementation on colitis-associated tumorigenesis and
inform the first guidelines for the use of FA supplements by patients with ulcerative colitis.

Public health relevance
Project Narrative Patients with ulcerative colitis often develop folate deficiencies and require supplementation with folic acid. The cancer preventive properties of folic acid remain controversial and few studies have focused on its activity in the setting of inflammatory bowel disease. An in-depth analysis of the impact of folic acid supplementation (high dietary intake) on risk for colitis-associated colorectal cancer is essential to ensure its safety and inform guidelines for its use in patients with ulcerative colitis who are known to be at increased risk for colorectal cancer.